Cancer Prevention and Control Program

CANCER PREVENTION AND CONTROL PROGRAM: ABSTRACT
The overall goal of the Cancer Prevention and Control (CPC) program is to understand and address high-
impact cancers and cancer-related disparities in Oklahoma (SCC catchment area), with a focus on disparities
in the state's American Indian (AI), Black / African American (Black/AA), rural, and other socioeconomically
disadvantaged populations. Specific aims of the program focus on: 1) identifying genetic, environmental,
behavioral, and social risk factors that contribute to high cancer incidence and disparities in Oklahoma; 2)
developing, evaluating and implementing interventions to reduce to cancer incidence and mortality; and 3)
improving cancer outcomes through enhancing care access, delivery and survivorship. Close interactions with
the Community Outreach and Engagement (COE) Associate Director (Mark Doescher, MD) and Core help
facilitate catchment area-focused research and community partnerships. CPC program aims have evolved
since the last CCSG, driven by center and program planning, new strategic opportunities, maturation of
program activities, and in response to emerging cancer problems in the catchment area. Revised program
aims now reflect a broader scope as well as greater integration and synergy of activity to address cancer in the
catchment area.
The CPC program has 43 members (25 full and 18 associate), representing 18 academic departments and a
range of transdisciplinary expertise, including: cancer health disparities, community-based participatory
research; novel interventions for tobacco prevention and cessation; emerging tobacco products; basic
mechanisms of addiction; care coordination, delivery and survivorship; and basic mechanisms of treatment-
related side effects. The CPC program made significant progress during past five years on all metrics for
programmatic activities. The CPC program has experienced significant increases in NCI ($2.64M  $3.65M)
and total peer-reviewed research funding ($5.58M  $7.27M) since the last CCSG, reflecting strategic
planning, targeted recruitment, allocation of developmental funds, and value-added support from the SCC. Key
publication metrics have also significantly increased since the last CCSG, including: intra-programmatic (36%
 40%), inter-programmatic (6%  29%), multi-institutional (64%  82%), and high impact (1%  8%)
[impact factor ≥10]. The nearly five-fold increase in inter-programmatic collaborative publications directly
addresses a program critique in the prior CCSG. The CPC program hosts numerous training and mentorship
programs for under- and graduate students, postdoctoral fellows and junior faculty. The CPC program is led by
Paul Spicer, PhD, Darla Kendzor, PhD, and C.V. Rao, PhD, who have diverse and complementary
transdisciplinary expertise to advance program aims.